Mild and Selective Cooperative-Base Mediated Hydrosilylations for Improved Drug Synthesis

Project Summary/Abstract
PI: Gregory O’Neil
Western Washington University
Title: Mild and Selective Cooperative-Base Mediated Hydrosilylations for Improved Drug Synthesis
Abstract: Reduction reactions are key transformations in the synthesis of both clinical and experimental drugs
used to treat various human diseases. Common reducing agents, however, can present certain hazards (e.g.
sensitivity to moisture and the release of flammable H2 gas) and/or require special handling and equipment.
Additionally, as the target molecules become more complex, selectivity requirements become more stringent
which drives the need for new easily performed and highly selective reduction protocols. This proposal describes
the use of organosilanes combined with cooperative-base activation to produce a mild, approachable, and
selective reduction method with which to access various biologically active molecules.
Both substrate-controlled diastereoselective hydrosilylations and chiral base-mediated enantioselective
carbonyl reductions will be investigated. The intramolecularity of these reactions is also expected to render the
transformations chemoselective (Aim #1). Regioselective epoxide openings will be accomplished that may
feature newly designed silanes and/or Lewis base activators (Aim #2). All of these reactions are expected to
generate dioxasilinane products that can then be further functionalized to generate valuable synthetic
intermediates that would otherwise be challenging to prepare (Aim #3). This is to be achieved by pursuing the
following specific aims:
1. Explore chemo-, regio-, and diastereoselective cooperative base-mediated intramolecular
hydrosilylations.
2. Perform mechanism-based optimizations of intramolecular hydrosilylations.
3. Investigate functionalization reactions of dioxasilinane intramolecular hydrosilylation products.
This work will have a significant positive impact on providing new and superior access to various important
synthetic intermediates through the combination of predictable selectivity, versatility, and mild reaction
conditions, as well as presenting significant training opportunities for undergraduate participants in various
research methods.

Public health relevance
Project Narrative The proposed research is relevant to public health because its success will facilitate the synthesis of new drugs to treat human disease. This project will utilize silicon-based reductants to provide new and superior access to structures commonly found in biologically active compounds through the combination of predictable selectivity, versatility, and mild reaction conditions. This is in line with part of NIH’s mission to reduce the burdens of illness and foster research strategies to improve health.